Investigating Rab8 Phosphorylation and AMPA Receptor Trafficking in the LRRK2G2019S Mutation

PROJECT ABSTRACT
Kinase enhancing mutations in Leucine-Rich Repeat Kinase 2 (LRRK2) are associated with both familial and
sporadic forms of Parkinson’s (PD), including the prevalent G2019S mutation. In brain, LRRK2 is highly
expressed in striatal projection neurons (SPNs) and cortical neurons. Our lab has previously shown significant
AMPA receptor (AMPAR) trafficking deficits in mouse Lrrk2G2019S SPNs, however the molecular mechanisms
underlying these trafficking deficits is unknown. LRRK2 phosphorylates a number of Rab GTPases, including
Rab8, and previous studies in hippocampal neurons suggest a role for Rab8 in AMPAR trafficking. Rab8’s
interactions with specialized proteins that maintain a tightly regulated activation cycle are impaired by LRRK2-
mediated phosphorylation, suggesting that Rab8 activity is further regulated by LRRK2 phosphorylation. How
Rab8 regulates AMPAR trafficking in SPNs, and the functional consequences of LRRK2-mediated
phosphorylation of Rab8, are not known. Preliminary evidence suggests that both phosphorylated and
unphosphorylated Rab8 interact with the AMPAR subunit GluA1 in vitro. Therefore, I hypothesize that Rab8
phosphorylation state regulates AMPAR trafficking in SPNs, and excess phosphorylated Rab8 (p72-Rab8;
pRab8) mediates AMPAR trafficking deficits seen in the Lrrk2G2019S mutation. To address these gaps, the
proposed experiments aim to characterize Rab8’s functional relationship with AMPAR trafficking pathways in
SPNs and explore the effects of LRRK2-mediated phosphorylation of Rab8 by combining genetic manipulations
of Rab8 with imaging, biochemical, and electrophysiological approaches.

Public health relevance
PROJECT NARRATIVE Elevations in LRRK2 kinase activity are causally related to Parkinson's, but the cellular mechanisms that are targeted to produce disease symptoms are poorly understood. The proposed work will generate neuronal maps of LRRK2 activity and pathology and will identify sites and targets of dysfunctional cellular trafficking mechanisms that are unable to support normal synapse plasticity. These data will help to identify molecular pathways that may be recruited or suppressed to preserve cognitive function or ameliorate symptoms in Parkinson's.